CHOLINE DEFICIENCY IN HUMANS

Choline is required to make essential membrane phospholipids. It is a precursor for the biosynthesis of the neurotransmitter acetylcholine and also is an important source of labile methyl groups. The purpose of this study is to determine if choline is an essential nutrient.